Project 1: Dynamic functional brain network phenotypes associated with vulnerability to hazardous alcohol consumption

Project 1: Dynamic functional brain network phenotypes associated with vulnerability to hazardous
alcohol consumption
Paul Laurienti, Colleen Hanlon, Heather Shappell, Mohsen Bahrami
This project is a continuation of the human neuroimaging studies examining brain networks associated with
drinking behaviors in the Wake Forest Translational Alcohol Research Center (WF-TARC). The overarching
hypothesis of this proposal that the vulnerability to develop hazardous drinking is manifest in dynamic network
connectivity within and between the default mode network (DMN) salience network (SN) and the sensorimotor
network (SMN). This hypothesis is based on a growing body of resting-state brain network studies suggesting
that hazardous drinking and AUD are associated with decreased DMN connectivity and increased SN and
SMN connectivity. However, much more research needed on these three intrinsic brain networks, particularly
evaluation of network dynamics. The primary goals of this project are to: (Aims 1 & 2) evaluate the network
dynamics associated with the development of hazardous drinking and (Aim 3) determine if non-invasive brain
stimulation directed at the medial prefrontal cortex (MPFC), a node in the DMN, modulates the network
dynamics. To achieve these goals the current study will use advanced quantitative analytics based on Hidden
Semi-Markov Modeling (HSMM) and machine learning predictive analytics to identify and characterize
functional brain network dynamics associated with vulnerability to developing hazardous drinking. The National
Consortium on Alcohol and Neurodevelopment in Adolescence (NCANDA) is a longitudinal study that
collected brain imaging and alcohol consumption history from adolescents over a 4-year period. This de-
identified and publically available dataset will be used to examine brain network dynamics associated with
hazardous drinking (Aims 1 and 2). We will also use de-identified longitudinal brain imaging data collected
before and after individuals with AUD received a course of continuous theta burst stimulation (TBS) or sham
treatment to the MPFC. This an ideal dataset to determine if dynamic network connectivity within and between
the DMN, SN, and SMN is responsive to non-invasive neuromodulation. Understanding the dynamic
interconnectivity within and between these circuits can guide future research designed to identify network-
based treatment strategies. For example, research on new targets for TBS delivery or behavioral interventions
that that rely on particular circuits can utilize information about individual dynamic connectivity profiles based
on the outcomes of the proposed studies.